Software or Web Services to Assess Quality and Reproducibility of Data and Information about Therapeutics and Vaccines

To develop digital tools that assess quality and reproducibility of research-based digital information related to therapeutics and vaccines for infectious diseases.